Kinetics of neo-vascularization during pulp regeneration

We have demonstrated that de novo pulp regeneration can be achieved via stem cell-based approaches. While
such progress signifies the ultimate clinical practice of pulp regeneration on patients, one critical issue exists
hindering the progress in this field: lack of timely vasculo/angiogenesis rendering inconsistent outcomes and
narrowing the cases suitable for such practice (limited to immature teeth with wide open apex). Additionally, the
kinetics of neo-vascularization during pulp regeneration is unknown. Without such knowledge, it is difficult to
advance to the next level of pulp regeneration.
Here, we propose to use combination of angiogenically induced dental pulp stem cells (DPSCs) and non-
induced DPSCs to enhance the neo-vascularization during pulp regeneration. Most importantly, we designed a
new study model that allows us to conduct real-time kinetic inspection of the cellular process during neo-
vascularization under this approach.
Overall hypothesis: Combination of angiogenically induced DPSCs and non-induced DPSCs allows
accelerated and stabilized neo-vascularization thereby timely blood perfusion with the host vascular system can
occur and more complete pulp regeneration can be reached. We will take the advantage of our newly designed
tooth fragment skin-fold window chamber model, tube model, as well as our well-established tooth fragment
model to test the hypothesis. Below are the Specific Aims.
Aim 1. To Investigate the kinetics of the neo-vascularization of pulp regeneration using newly designed
study models.
• To use combination of angiogenically induced DPSCs that become endothelial-like cells (DPSC-ECs)
and non-induced DPSCs for neo-vascularization.
• To use tooth fragment skin-fold window chamber model to investigate the enhancement of
vascularization and blood perfusion from the host vasculature to the engineered vasculature in real time.
Aim 2. To investigate the neo-vascularization mechanism and long-term neo-vascular stability of
regenerated pulp.
• To examine molecular mechanisms of engineered vasculo/angiogenesis and anastomosis during pulp
regeneration using tooth fragment skin-fold window chamber model.
• To examine survival and long-term stability of engineered vasculature formed by DPSC-ECs plus DPSCs
as well as the quality/quantity of the regenerated pulp in the tooth fragment model.
The success of this project will allow this field to move closer to clinical applications, and potentially
establishing a technology widely used in clinical endodontics.

Public health relevance
Current root canal therapy damages the tooth structure, therefore, in the recent past our team has developed a stem cell-mediated approach by regenerating damaged root canal tissues. This new technology, however, still faces challenges due to limited blood supply during regeneration. In this proposal we aim at resolving this barrier by exploring new approaches which may advance this new technology closer to clinical applications.